Light-Activated SIte-Specific Conjugation (LASIC) to accelerate clinical translation of catheter-directed antibody-drug-conjugate labeled theranostic microbubbles in an Oncopig liver tumor model

PROJECT SUMMARY
While conventionally known as contrast agents for diagnostic ultrasound, gas-encapsulated
microbubbles can also be functionalized with targeting antibodies and therapeutic payloads. This unique
delivery mechanism allows for improved therapeutic index in difficult-to-reach locations, minimizing the risk for
off-target effects. However, the potential of microbubble theranostic agents has not yet been fully realized
because of current limitations in conjugating antibodies and therapeutic agents to the microbubble itself. These
limitations include difficulties in conjugating the antibodies in the right alignment on the microbubble while
preserving microbubble integrity. It is also unclear what the pharmacokinetic characteristics of the theranostic
microbubbles will be in a clinically-relevant large animal model. We plan to overcome these limitations using a
novel site-specific labeling technique known as Light Activated Site-Specific Conjugation (LASIC) technology.
Leveraging LASIC to attach both targeting antibodies and therapeutic payloads will streamline the theranostic
microbubble manufacturing process, facilitating its translation into the clinical population. With successful
LASIC-optimization of microbubbles, the biodistribution of these microbubbles will be further improved via
image-guided catheter delivery. This project will be conducted via 3 aims: 1) Creating targeted microbubbles
using LASIC technology: We will test the feasibility of LASIC on commercially available avidin-coated, and
then the less immunogenic azido-lipid-based microbubbles. Efficacy of microbubble-cell binding will be
evaluated using in vitro assays and ultrasound phantoms. We will then 2) Generate theranostic
microbubbles using LASIC to attach therapeutic payloads to the microbubbles. In this aim we will also
augment microbubble payload release via non-invasive sonoporation, using in vitro techniques to optimize
drug delivery. Lastly, we will 3) validate the safety and pharmacokinetic profile of the LASIC-optimized
microbubbles large animal tumor model, also known as the Oncopig. The microbubbles will be delivered
via a clinically relevant image-guided catheter, allowing for maximum therapeutic index in the target tumor. The
results of this project will have significant implications for the translatability of microbubble platforms for
theranostic purposes. By minimizing disruption of the phospholipid shell, LASIC can potentially revolutionize
the way microbubbles are currently conjugated. The potential implications of this research extend well beyond
the immediate impact of microbubble conjugation chemistry, paving the way for future advancement in
theranostic agents, image-guided interventions, and large animal validation modeling.

Public health relevance
PROJECT NARRATIVE Microbubbles can be conjugated with both targeting antibodies and therapeutics payloads to become powerful theranostic agents. In this project, we plan to use Light Activated Site-Specific Conjugation of Native IgGs (LASIC) technology to perform site-specific conjugation of antibodies and therapeutic payloads onto microbubbles. These microbubbles will then be validated using clinically relevant delivery in a large animal model, facilitating future translation into the patient population.